Leptin regulation of GABAergic synaptogenesis and excitation-inhibition balance during development: effects of maternal obesity

Leptin is a critical neurotrophic factor during development. Its receptors (LepRs) are found throughout the
brain, including in the hippocampus. Leptin deficiency is also associated with cognitive and emotional
impairment, behaviors impacted by hippocampal function. Intriguingly, leptin levels rise during a critical
developmental period when hippocampal synaptogenesis is occurring. We have demonstrated that leptin
induces GABAergic synaptogenesis and controls Cl- homeostasis to promote an excitatory effect of GABA
during this critical period. In contrast, a lack of leptin shifts the excitation/inhibition balance so that GABA is
more inhibitory, and reduces GABAergic synaptogenesis. Excessive leptin during development
(hyperleptinemia) prolongs the excitatory action of GABA and increases GABA receptor expression,
suggesting that it may have long-term effects on hippocampal function. Intriguingly, leptin levels are
elevated in children with early onset autism spectrum disorders (ASD) and Rett syndrome, a disease
showing “autistic-like” behaviors. Maternal obesity, which affects 1 in 5 pregnancies, is also associated with
hyperleptinemia in humans, and also heightens the risk of ASD and other neuropsychiatric disorders in
children. One potential mechanism by which maternal obesity, and the associated hyperleptinemia, could
impact the likelihood of a child or an adult developing emotional and cognitive disorders is through
alterations in the development, maintenance, function or plasticity of GABAergic connections. However, the
effects of hyperleptinemia and maternal obesity on the development and function of GABA synapses is not
known. Understanding how maternal obesity alters the developmental effects of leptin and the formation of
critical hippocampal synaptic connections in vivo is an essential first step to understanding the mechanisms
by which maternal obesity impacts hippocampal function later in life. Our central hypothesis is that leptin
plays a key role in regulating GABAergic synaptic development and plasticity and that pathological
hyperleptinemia alters this process through changes in the expression and membrane localization of key
components of GABAergic synapses and regulators of Cl- homeostasis. We will test our central hypothesis
with three specific aims. 1) Determine how leptin alters Cl- homeostasis and stimulates GABAergic
synaptogenesis in vivo 2) Determine whether developmental leptin impacts GABAergic synaptic function
and plasticity. 3) Determine if maternal obesity and associated hyperleptinemia alters GABAergic
synaptogenesis, Cl- homeostasis and GABAergic synaptic function and plasticity. While we have focused
on the hippocampus, this knowledge is expected to have broad impact, as it should also be applicable to
leptin-induced synapse formation in other brain regions, including pathways critical for the control of food
intake and energy homeostasis. This research therefore should have implications for both mental health
disorders, such as mood, cognitive disorders and metabolic disorders such as obesity.

Public health relevance
The proposed research is relevant to public health because it addresses how maternal obesity impacts neuronal development. It is expected to identify critical signaling mechanisms by which neurotropic factors, such as leptin, control GABAergic synaptic development; disruption of which causes depression, cognitive disorders and Autism Spectrum Disorder. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to elucidating how obesity impacts development and developing targeted approaches for the prevention and treatment of obesity and mental health disorders, such as Autism spectrum disorder, depression, anxiety and cognitive function.